Randomized Controlled Trial of an Adapted Evidence-Based Coaching Program for Fathers and their Young Children in the Context of Home Visiting

Abstract: There is now overwhelming consensus that fathers’ influences on children’s development begin
before birth and continue throughout the lifespan, with the early childhood period representing a particularly
opportune time for programs to engage fathers. Studies of low-income fathers have found that warm and
responsive interactions between fathers and their young children uniquely contribute to children’s social,
emotional, and other skills, even after controlling for mothers’ parenting contributions (Amodia-Bidakowska et
al., 2020; Mills-Koonce et al., 2015; Shannon et al., 2002). Early childhood is also the developmental period in
which fathers across family structures and socioeconomic statuses are most likely to be involved in their
children’s lives (Carlson & McLanahan, 2010). This suggests a window of opportunity for supporting fathers
during children’s earliest years, which may help shape fathers’ involvement and relationships with their
children over the lifespan. Despite this growing evidence, early childhood programs continue to focus largely
on mother-child interactions, few interventions for low-income fathers have focused on parenting skills, and
fewer still have focused on contingent responsiveness. The limited number of rigorous evaluations of fathering
programs means we also lack substantial evidence on the causal links between participation in such programs
and changes in father and child outcomes (Osborn, 2014). We aim to address these gaps by conducting a
randomized controlled trial of a 6-week video coaching program, Filming Interactions to Nurture Development
(FINDF), with fathers and their young children. FINDF is delivered through flexible home visits, targets warm
and responsive father-child interactions, and uses video recordings to emphasize each father’s parenting
strengths in the context of everyday caretaking moments. The sample will comprise of 200 racially and
ethnically diverse fathers and their children ages 12-36 months whose families are enrolled in our community
partner’s Early Head Start and related early childhood programs. Father-child pairs will be randomized to
FINDF or a waitlist control group. Assessments comparing the two groups will occur at baseline, end of
program, and 6 months post-program. We propose the following aims: 1) evaluate the main impacts of FINDF
on the primary program target (i.e., fathers’ supportive parenting) and related child and parent outcomes (i.e.,
children’s behavior problems, children’s social-emotional competence, fathers’ parenting stress, fathers’
involvement, and father identity), 2) identify mechanisms of FINDF’s intervention effects, and 3) examine
variation by select child, father, and program measures. Together, these aims will test the effectiveness of
FINDF as well as how, for whom, and under what conditions FINDF works best or least. This will be one of the
first large-scale randomized controlled trials focused on evaluating the impacts and underlying theory of a
nurturing fathering program and builds upon promising findings from two preliminary evaluations of FINDF.

Public health relevance
Narrative: The proposed study will significantly advance our scientific knowledge about fathers’ parenting and child development in the context of a rigorous evaluation of a parenting program. This project will also increase the reach of early childhood parenting programs into a population of parents that prior studies have consistently reported is difficult to engage and will increase understanding of variations in the intervention’s effects over time to inform future strategies. This work is particularly relevant to the part of NICHD's mission focused on understanding human development and enhancing the lives of children.